Longitudinal Risk Factor Changes and Early Recognition of Cerebral Small Vessel Disease

Cerebral small vessel disease (CSVD) is strongly related to Alzheimer’s disease (AD), related dementias
(ADRD), stroke, and vascular cognitive impairment,1 is severe in 30–50% of patients with AD,2 and contributes
to about 30% of all dementia cases.3 CSVD remains in subclinical stages for years to decades and can be readily
assessed using clinical brain MRI. CSVD is most frequently the consequence of long-term exposure to modifiable
risk factors, but such risk factors as well as healthy behaviors change within and between individuals over a
lifetime and are further altered by treatments. These changing relations with CSVD burden remain to be fully
elucidated, which is critical to understand the duration of vascular risk factor exposure that could lead to
irreversible brain injury and should prompt assessment of CSVD burden to enhance preventive efforts. Using
novel applications of functional data analysis we will leverage the richly characterized long-term data acquired
over up to 7 decades of follow-up in the prospective Framingham Heart Study, and readily available traditional
MRI (available in clinical practice) to relate trends and duration of exposure to vascular risk factors, American
Heart Association (AHA) life’s essential 8 and preventive treatment use to a total CSVD score (T-CSVD) that
provides a comprehensive assessment of CSVD manifestations in individuals. We will further study the role of
T-CSVD scores for prediction of dementia and stroke using traditional assessments of individual CSVD
measures (covert brain infarcts, white matter hyperintensities, cerebral microbleeds, cortical superficial siderosis
and enlarged perivascular spaces), and contrast with novel scores incorporating sensitive measures of white
matter injury based on diffusion tensor imaging, and molecular imaging based on amyloid and Tau PET
measures available in a subset of participants.
Success of our exploratory application will provide a practical assessment of total cerebral small vessel disease
in relation to incident stroke and dementia, using CSVD measures available in clinical care, and much needed
insight into: i) the age at which assessment of CSVD burden should be considered in clinical practice, and/or ii)
the duration of exposure to risk factors that should lead to consideration of CSVD burden assessment. If our
application is successful, it may change clinical practice to promote assessment of CSVD burden in subclinical
stages for early implementation of preventive treatments.

Public health relevance
Cerebral small vessels (CSVD) detected on brain MRI signals increased risk of stroke and dementia, frequently years to decades before their occurrence. We propose to use novel functional data analysis applications to relate life-long vascular risk factor data to CSVD to understand critical exposure durations that should prompt assessment of CSVD burden and life stage when it could be considered. We will also assess prediction of stroke, Alzheimer’s dementia and other related dementias using a total T-CSVD score. Findings in our proposal could lead to early assessment of CSVD burden for the prevention of stroke and dementia.